Sputum Tph cells and CD14+CD16+ monocytes in the development of RA

PROJECT SUMMARY/ABSTRACT
Formation of disease-associated autoantibodies (Abs), including anti-cyclic citrullinated peptide (CCP) and
rheumatoid factor (RF), is an early step in the pathogenesis of rheumatoid arthritis (RA). In fact, RA-Abs can
develop several years before the onset of joint inflammation during a preclinical phase of RA development. Our
preliminary data found that the presence of RA-Abs in sputum during preclinical RA is strongly associated with
development of classified RA in 3 years. Yet, there is a major gap in our understanding of the cellular mecha-
nisms leading to RA-Ab generation in the lung in preclinical RA. The overall hypothesis of the proposed project
is that CD4+PDhiCXCR5- T peripheral helper (Tph) cells and CD14+CD16+ intermediate monocytes in the lung
contribute to the sputum RA-Ab generation that predicts transition from preclinical to classifiable RA. This hy-
pothesis is based on our published and preliminary data including our finding that Tph cells and CD14+CD16+
monocytes are increased in the peripheral blood of individuals At-Risk for RA (i.e., in the preclinical phase of
RA based on serum anti-CCP positivity) compared to controls. Tph cells are known to promote B cell differenti-
ation and antibody production in inflamed non-lymphoid tissues, such as the lung. Moreover, we found in pre-
liminary data that sputum RA-Ab levels strongly correlated with sputum IL-6 levels, which can promote B cell
differentiation and antibody production and can be produced at high levels by CD14+CD16+ monocytes. The
proposed ancillary studies will leverage induced sputum samples already being collected as part of an ongoing
parent R01 study. This 1-year study will include individuals At-Risk for RA, individuals with classified RA and
healthy controls. The study will quantify the proportion of T and B cell subsets, including Tph cells, in sputum
using flow cytometry. In At-Risk subjects, the % Tph cells will be correlated with levels of sputum RA-Abs and
Tph-associated cytokines (IL-21, CXCL13). T cell subsets will also be sorted by FACS and undergo bulk RNA
sequencing. It is expected that sputum Tph cells will be increased in individuals At-Risk for RA, correlate with
sputum RA-Abs and have a distinct transcriptional profile reflecting a role in B cell differentiation and antibody
production. The proposed project will also quantify the proportion of monocyte and macrophage subsets in
sputum using flow cytometry. In At-Risk subjects, the % CD14+CD16+ monocytes in sputum will be correlated
with levels of sputum RA-Abs and IL-6. Bulk RNA sequencing will be performed on monocyte and macro-
phage subsets isolated by FACS. It is expected that sputum CD14+CD16+ monocytes will be increased in indi-
viduals At-Risk for RA, correlate with sputum RA-Abs and have a distinct transcriptional profile associated with
IL-6 production. Altogether, this proposal will further the strategic vision of the NIH by investigating novel cellu-
lar mechanisms in the lung that contribute to the RA-Ab generation associated with transition from preclinical to
classified RA and could serve as novel cellular targets for disease prevention in RA.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis (RA) affects approximately 1% of the population and can lead to significant morbidity, in- creased mortality, and substantial health-care and societal costs. This project will study two immune cell sub- sets from the lung to understand whether they are involved in the production of RA-related antibodies in the lung during the early phases of RA development. Ultimately, these findings can lead to novel approaches for RA prevention that target these cells or proteins produced by these cells.